Personalized Integrated Chronotherapy for Perinatal Depression

Perinatal depression and anxiety are common, serious, and frequently overlapping disorders that increase
morbidity and mortality in new mothers (including suicide) and result in poor infant/child outcomes. Current
therapies often fail to produce recovery or are poorly tolerated, and many pregnant women seek non-
pharmacologic therapy or forgo treatment when non-pharmacologic options are not available. Expectant and
new mothers who experience circadian rhythm dysregulation are at increased risk for perinatal depression.
This Confirmatory Efficacy Clinical Trial of Non-Pharmacological Interventions for Mental Disorders R01 seeks
to test whether a Personalized Integrated Chronotherapy (PIC) intervention can improve treatment outcomes
for pregnant patients seeking outpatient treatment for depression, with or without anxiety. PIC is a
multicomponent treatment consisting of bright light therapy, sleep phase advance, and sleep stabilization/restriction that targets the Research Domain Criteria (RDoC) constructs of circadian rhythms and sleep-wake behavior. To increase sample size and diversity and accelerate recruitment, this study will be performed at 4 sites that differ in clinical structure and that have piloted the PIC intervention. The study will enroll expectant mothers diagnosed with major depressive disorder during 3rd trimester of pregnancy. We will randomize patients to either:
(a) usual care (UC, n = 110) or (b) PIC+UC (n = 110). PIC+UC will have pregnancy and postpartum
components and will be administered via a personalized approach tailored to optimize the intervention based on each patient’s individual circadian and sleep timing. After a baseline assessment, PIC will be prescribed during 5
dedicated clinical visits: three during 3rd trimester of pregnancy and 2 in the postpartum period. UC will consist
of medication and/or psychotherapy. UC will be quantified in both groups to evaluate differences between the
PIC+UC and UC groups. Mood will be measured in both groups by blinded clinician interview and patient self-
report. The safety profile of the PIC intervention will be assessed by evaluation of side effects/adverse events.
Importantly, the study will also examine the target mechanisms by which PIC is hypothesized to work and test
the mediation effects of the circadian targets on improvement in mood symptoms. Participants will wear wrist
actigraphy/light monitors continuously during weeks 28-40 of pregnancy and postpartum weeks 2-6 to assess
light exposure and to estimate sleep timing and duration. Circadian phase (measured with salivary dim light
melatonin onset) will be measured at baseline during pregnancy (~30 weeks’ gestation), at 36 weeks’ gestation,
and at postpartum week 6. Exploratory aims will examine associations between infant sleep behavior and
maternal circadian rhythms and factors relevant to future dissemination of PIC. If this intervention is effective,
perinatal PIC could change clinical practice and have major public health impact due to the high prevalence of
perinatal depression and anxiety, the negative effects of mood disorders on mothers and their children, and the
need to provide effective, novel, non-pharmacologic therapies for women with perinatal mood disorders.

Public health relevance
Perinatal depression is a serious mood disorder that causes suffering, can lead to suicide in new mothers, and results in poor maternal/child outcomes. This study will determine if a non-pharmacologic treatment for depression (personalized integrated chronotherapy) is efficacious in pregnant and postpartum women seeking care for perinatal depression in an outpatient setting. This intervention could change clinical care and have major public health impact due to the high prevalence of perinatal depression, and may be of particular use among women who are reluctant to take medications for depression during pregnancy or while breastfeeding.